Body composition and adiposity-associated thromboinflammation in colorectal cancer prognosis

SUMMARY
Obesity increases the risk of numerous cancers including colorectal cancer (CRC). With the growing global
epidemic of obesity, a greater understanding of the obesity cancer-link, including its underlying biology and its
adverse influence on patient outcomes is critically needed. Our ability to treat patients optimally has been
hampered, in part, by the traditional use of body mass index (BMI) to define obesity. BMI fails to take into
account important dimensions of body composition, such as fat distribution (e.g., visceral obesity) and muscle
mass (e.g., sarcopenia). A clinically applicable approach to characterizing obesity and body composition
combined with an understanding of CRC-obesity biology will advance our ability to tailor treatments and
interventions to disrupt the adverse impacts of obesity on treatment toxicity and patient outcomes. We propose
an interdisciplinary study that addresses both gaps in knowledge by (1) application of a cutting-edge artificial
intelligence (AI)-powered, fully automated CT scan-based platform to generate accurate, individualized
volumetric measures of adipose tissue compartments/skeletal muscle mass and (2) testing the role of
thromboinflammation, a novel biologic pathway to investigate in the context of obesity-CRC outcomes.
Thromboinflammation, a state characterized by increased platelet activation and systemic and tumor-specific
sequelae, plays a role in metastasis and has recently, but separately, been associated with obesity and
cancer; however, it has never before been investigated as a biological interface and potential target of
intervention in the obesity-CRC link.
Our study leverages a unique resource of longitudinal CT images, clinical data, tumor, plasma, and urine
from a population of N=1,200 stage I-III CRC patients enrolled in the NCI-funded ColoCare Study. In Aim 1,
we will apply a novel AI-powered fully automated radiologic 3D body segmentation software to generate robust
volumetric adiposity and muscle mass profiles and examine associations with treatment-related toxicity and
clinical outcomes. In Aim 2, we will examine thromboinflammation biomarkers in blood, urine, and tumor in
relation to visceral obesity and survival outcomes and test whether this pathway mediates Aim 1 associations.
Together, we will discern differences by race and other factors (e.g., age, sex, stage, and tumor site)
The proposed project takes a powerful and rigorous team science approach to address key questions on
the impact of body composition and adiposity-promoted thromboinflammation on CRC treatment-related
toxicities and survival. Use of a single, large, study patient population with an exceptional set of uniformly
available CT scans, data, and biospecimens is cost-effective and maximally informative. Our study will not only
yield clinically meaningful prognostic measures of body composition and thromboinflammation but will also
provide insights into obesity-CRC biology with the potential to identify novel personalized treatment strategies.

Public health relevance
NARRATIVE With the growing global epidemic of obesity, a greater understanding of the link between obesity and colorectal cancer outcomes is an important clinical challenge to address. Using innovative, state-of the-art methods, this study will identify the specific components of adipose tissue distribution and muscle mass that predict colorectal cancer treatment tolerance and survival. By applying a parallel comprehensive assessment of platelet activation, and related biomarkers in the blood, urine, and tumor, we will test, for the first time, the role of thromboinflammation in promoting colorectal cancer progression.